METABOLIC BASIS ROLE OF IGF I IN IMPAIRED VASCULAR REACTIVITY IN DIABETES

This study is evaluating whether acute and chronic IGF-I therapy reverses endothelial dysfunction and impaired vasodilation in subjects with diabetes mellitus.